Immunoregulatory Role of Conventional Dendritic Cell Type 2 in Allergic Lung Inflammation

Project Summary
Asthma is a chronic airway disease in which diverse immune cells participate in the development and eventual
resolution of allergic lung inflammation. Among these immune cells, conventional dendritic cell type 2 (cDC2)
plays a fundamental role in bridging innate and adaptive immunity. However, recent studies show that the
cDC2 population is diverse and heterogeneous, unlike the more homogenous cDC1. Our group has
characterized the heterogeneous cDC2 subsets with distinct transcriptomic features in the lung and
demonstrated that a unique pro-inflammatory cDC2 subset, CSF1R+cDC2, is necessary for sensing inhaled
allergens. Our supporting data for this proposal show that CX3CR1 is predominantly expressed by cDC2 but
not cDC1 in mouse and human lungs, indicating that CX3CR1+cDC2 is another unique cDC2 subset. In mice,
we compared the gene expression patterns between CX3CR1+cDC2 and their receptor-negative counterparts.
Remarkably, the gene expression pattern of CX3CR1+cDC2 was skewed towards anti-inflammatory pathways.
This corresponds with prior reports indicating an immunoregulatory role for CX3CR1 expressing myeloid cells,
and our own published data showed that CX3CR1+ lung macrophages facilitated the resolution of allergic lung
inflammation. This proposal aims to examine the mechanisms by which CX3CR1+cDC2 has the role of a
contrasting anti-inflammatory role in allergic lung inflammation. To analyze the functions of the CX3CR1+cDC2,
we generated several novel transgenic mice to deplete them selectively or knockout CX3CR1 in a cDC2-
specific way. Our data show that depletion of CX3CR1+cDC2 results in a marked reduction in CD4+Foxp3+
regulatory T cells (Tregs) and the delayed resolution of allergic lung inflammation with delayed resolution. In
addition, CX3CR1+cDC2 expressed higher levels of the co-inhibitory molecule PD-L1 compared to their
receptor-negative counterparts. These data strongly suggest that lung CX3CR1+cDC2 is an anti-inflammatory
subset of cDC2, which plays an essential role in the resolution of allergic lung inflammation.
In this proposal, we will characterize the anti-inflammatory role of the lung CX3CR1+cDC2 subset and
determine the immunologic mechanisms by which the CX3CR1+cDC2 regulates allergic lung inflammation. To
do so, we will first determine whether CX3CR1+cDC2 drives Treg development. Next, we will characterize the
molecular signalings via MHC classes and PD-L1, contributing to CX3CR1+cDC2-mediated anti-inflammatory
function. Finally, we will seek to elucidate the human relevance of this unique lung cDC2 as an anti-
inflammatory subset, using human BAL cells and intrathoracic lymph nodes obtained by bronchoscopy. In
summary, these proposed experiments are designed to uncover a novel anti-inflammatory role of the
CX3CR1+cDC2 subset in the resolution of asthmatic inflammation. These data will significantly expand the
understanding of the processes involved in the resolution of allergic lung inflammation and delineate novel
treatment options.

Public health relevance
Project Narrative Dendritic cells are a type of immune cells orchestrating various immune responses, and recent studies indicate that dendritic cells are a heterogeneous population, coordinating immune responses either toward promoting or suppressing inflammation. Although the pro-inflammatory role of dendritic cells is well known, the cellular characteristics of an immunosuppressive subset of lung dendritic cells remain unknown. This proposal investigates the unique subset of the lung dendritic cells, which play a key role in suppressing allergic lung inflammation.